Leveraging North-South Partnerships to Advance Cell and Gene Therapy Research Training for HIV in Uganda (C>-Uganda)

There are ≈ 38 million people living with HIV, 67% of whom are in Sub-Saharan Africa (SSA). Despite the
success of antiretroviral therapy (ART), there is no approved HIV vaccine or cure. Research and development
(R&D) of gene and cell therapies has made progress e.g. innovative strategies to induce host resistance,
immunoreactivity against HIV or making host cells unable to produce viable virions. On-going efforts include
≈40 clinical trials but none include Africa. Given the high genetic diversity of populations in SSA and the fact
that the brunt of the burden is in SSA, it is critical that SSA should be involved in ongoing R&D. In 2020, the
Joint Clinical Research Center (JCRC), Fred Hutchinson Cancer Center (Fred Hutch) and Caring Cross
founded the Global Gene Therapy Initiative (GGTI) to include low-and-middle income countries e.g. Uganda
in ongoing HIV cell and gene therapy R&D. A preliminary assessment at JCRC showed health workforce
capacity gaps in almost all stages of R&D of gene and cell therapies including translational research. This is
also the case at other premier research and tertiary institutions in Uganda. To address this, JCRC has sent
her scientists for training in the US, and hereby propose a D71 planning process titled Leveraging North-
South Partnerships to Advance Gene and cell Therapy Research Training for HIV in Uganda (G&CT-Uganda)
in collaboration with Makerere University (Mak) and Fred Hutch. The goal is to prepare a D43 application for
an HIV research training program in Gene and cell Therapy at JCRC and Mak. Specific Aim 1 (develop a
robust strategic plan for efficiently leveraging JCRC’s North-South partnerships to plan for a research training
program in Gene and cell Therapy for HIV) will be achieved through face-to-face/virtual meetings,
consultations and a workshop with leaders from collaborating institutions. Specific Aim 2 (assess the critical
faculty development needs in Gene and cell Therapy for HIV research at Ugandan institutions), and Specific
Aim 3 (assess the training needs of potential trainees that are interested Gene and cell Therapy for HIV
research in Uganda) will be achieved through a training needs assessment i.e. desk review of current training
curricular, programs, faculty and resources at collaborating institutions; ii) key informant interviews and on-
line surveys among trainers, admissions officers and leaders at collaborating institutions; and iii) focus group
discussion among prospective trainees i.e. undergraduate and graduate students and Mak and Mbarara
University of Science and Technology. Specific Aim 4 (describe the envisioned research training program in
Gene and cell Therapy for HIV and identify/develop new training modules and courses to include), and
Specific Aim 5 (describe trainee recruitment approaches) will be achieved through meetings, consultations
and workshops with trainers, curriculum developers and leaders at collaborating institutions. Specific Aim 6
(develop and submit a D43 application to the National Institutes of Health) will be achieved through weekly
meetings, writing sessions and a 14-day writing retreat involving C> program faculty.

Public health relevance
Although antiretroviral drugs have revolutionized the management of HIV, they still need to be taken for life, new infections and deaths continue to occur the fast-track strategy to control the epidemic by 2030 may not be met. New tools are required to get the world on track to bring HIV infection under control in sub-Saharan Africa and globally and the most impactful advance would be development of an HIV cure using HIV gene therapy which is the frontrunner today but also in line with NIH priorities of research to develop next generation of HIV therapies and discovery of a cure for HIV/AIDS. A cure strategy that prevents reinfection would revolutionize HIV management, and constitute a onetime intervention with high impact on quality and quantity of life with phenomenal clinical, economic and social value.